Yoga Postures and Slow Deep Breathing in Altering Mechanistic Outcomes in Hypertension

Project Summary
Hypertension is a pervasive disease with rising mortality rates in the U.S. Although complex, hypertension
pathophysiology entails disruptions in vascular homeostasis driven by increased immune cell reactive oxygen
species and subsequent oxidative stress. Yoga's blood pressure-lowering effects have been elucidated;
however, the mechanisms are unknown. Our studies have found significant enhancements in flow-mediated
dilation, a nitric oxide dependent measure of vascular health, following yoga interventions. As oxidative stress
leads to reductions in nitric oxide bioavailability, it is possible that reductions in reactive oxygen species and
improvements in redox homeostasis represent a biological mechanism by which yoga improves vascular
function. Markers of oxidative stress have improved with yoga; however, immune cells, which are key sources
of reactive oxygen species in hypertension, have not been investigated in prior yoga studies. NADPH oxidase
expediates disease progression in hypertension via enhanced reactive oxygen species scavenging of nitric
oxide, compromised endothelium-dependent vasodilation, and resultant increases in total peripheral resistance.
While NADPH oxidase has declined following aerobic exercise interventions, this key enzyme has never been
explored in yoga research. The proposed study will investigate immune cell reactive oxygen species and NADPH
oxidase as biological mechanisms accounting for yoga's vascular and hemodynamic effects in unmedicated
adults with elevated blood pressure or stage I hypertension (Aim 1). In response to 12-week yoga interventions,
we will explore reactive oxygen species and NADPH oxidase in peripheral blood mononuclear cells as primary
and protein carbonylation, a consequence of oxidative stress, and superoxide dismutase, a marker of antioxidant
capacity, as exploratory outcomes. We will also establish a timeline of alterations in molecular, vascular, and
hemodynamic outcomes by incorporating measurements at 4-week intervals. We hypothesize that oxidative
stress markers will improve in response to the yoga intervention and these changes will be associated with
reductions in blood pressure and enhanced endothelial function. As yoga is a composite of postures and slow,
deep breathing practices, we will also delineate the contribution of slow deep breathing in modulating these
mechanistic outcomes (Sub-Aim 1). Slow, deep breathing alone has resulted in favorable alterations in blood
pressure and vascular function. We therefore postulate that slow deep breathing alone will be as effective as
yoga in improving BP-related mechanistic outcomes. This study serves as an initial step in the PI's long-term
goal of delineating mechanisms by which yoga could lower the risk of or serve as a therapeutic intervention for
cardiovascular diseases. This research is significant in that it could establish the role of the immune system in
altering clinical outcomes with yoga in hypertensive adults. As oxidative stress also plays a role in other diseases
marked by disruptions in vascular homeostasis, results could unveil a mechanism by which yoga could
ameliorate other conditions as well.

Public health relevance
Project Narrative Yoga lowers blood pressure in individuals with hypertension but it is unknown how these changes occur. The proposed study will investigate immune cell free radicals, which contribute to the pathology of hypertension, as a mechanism explaining yoga's blood pressure-lowering effects. Results from this study will lend insight into how yoga changes the bodily environment to facilitate favorable effects in hypertension and lend insight into the role of yoga in lowering the risk of cardiovascular disease.